Examining Mu Opioid Mechanisms of Ketamine's Rapid Effects in OCD

PROJECT SUMMARY
Obsessive-compulsive disorder (OCD) typically starts in childhood, leads to lifelong morbidity, and
costs the economy $2.1 billion (direct costs) and $6.2 billion (indirect costs such as lost productivity) annually.
OCD often responds inadequately to serotonin reuptake inhibitors (SRIs). Moreover, the typical SRI response
is only partial and is delayed by 2-3 months. Given the dysfunction OCD imposes on millions of U.S. adults,
exploring whether SRI non-responders are helped by adding drugs with different mechanisms of action is
urgently needed. Emerging data support ketamine’s rapid and sustained anti-obsessional effects in OCD. We
seek to understand the mechanisms underlying ketamine’s rapid OCD effect and thereby to speed
development of more effective agents for OCD.
For several reasons, this proposal focuses on ketamine’s action on the mu-opioid system and OCD
neural circuits. First, our prior work found that the mu-opioid receptor antagonist naltrexone blocks ketamine’s
acute, dramatic antidepressant effects. Second, naltrexone also worsens OCD symptoms, while morphine (a
mu-opioid receptor agonist) diminishes OCD symptoms. Third, in major depression, attempts to develop follow-
on agents that work via NMDA antagonism have not been successful. One possible explanation is that NMDA
antagonism may not fully explain ketamine’s rapid and enduring antidepressant effects. To assess the neural
targets modulated by mu-opioid receptor antagonism, we focus on fronto-striatal cognitive control circuits
which neuroimaging studies show are directly influenced by the mu-opioid system. Indeed, mu-opioid receptors
are distributed throughout the fronto-striatal circuits associated with OCD. Drawing on this rationale, the
proposed mechanistic trial would be the first to probe the role of ketamine’s opioid properties in modulating
fronto-striatal circuitry and bringing about anti-obsessional effects in OCD.
We will test, by administering pre-treatment with naltrexone, whether opioid receptor antagonism blocks
ketamine’s effects on control and reward circuits and circuit connectivity. Low-cost markers of opioid system
engagement that predict anti-obsessional response are needed. We will therefore explore two promising, low-
cost markers of opioid system engagement in humans. The proposed projects combine experimental
medication and neuroimaging approaches in order to open a new avenue for therapeutics to transform
psychiatric treatments.

Public health relevance
PROJECT NARRATIVE Obsessive-compulsive disorder (OCD) often responds inadequately to serotonin reuptake inhibitors (SRIs). Given the morbidity and dysfunction OCD imposes on millions of U.S. adults, exploring whether SRI non- responders are helped by adding drugs with different mechanisms of action is urgently needed. Emerging data support ketamine’s rapid and sustained anti-obsessional effects in OCD. The proposed mechanistic trial would be the first to probe the role of ketamine’s opioid properties in modulating fronto-striatal circuitry and bringing about reduction of OCD symptoms.